Clinical translation of a NexGen platform for quantifying protein networks in human biospecimens

PROJECT SUMMARY
In this competitive renewal for the Academic-Industrial Partnership (R01CA235575) between the Fred
Hutchinson Cancer Center and AstraZeneca, we will continue to advance the clinical translation of multiple re-
action monitoring mass spectrometry (MRM-MS) protein assays into the clinical trial setting. The MRM-MS tech-
nology is agnostic to the patient population. In the first funding cycle, our AIP successfully (a) optimized the MRM
assay technology for use on small clinical biospecimens; (b) developed and optimized reagents and SOPs for
controlling sample processing variation, calibrating assay results across samples & labs, maximizing sensitivity
of the platform for analysis of small volume clinical biospecimens, & improving methods for greater multiplexing;
(c) developed novel methods to account for microheterogeneity in tissue biospecimens; (d) achieved analytical
validation of MRM-based assay panels in our CLIA environment; (e) translated MRM-MS protein assays into
clinical trials, & (f) licensed the technology for commercialization. Data that we generated during the first funding
cycle uncovered an exciting opportunity and a new technological challenge. Specifically, some of the MRM-
based assays that we translated into clinical trials enabled quantification of phosphosignaling in the DNA Dam-
age Response (DDR) network. These assays are of high interest to our biopharmaceutical partners since the
DDR network is a major target for cancer drugs. Excitingly, our data indicate that analyzing DDR network signal-
ing through serial collections of peripheral blood mononuclear cells (PBMCs) before and after treatment can
provide meaningful pharmacodynamic data via a simple blood draw (vs invasive tissue sampling). Yet, the chal-
lenge lies in the low basal DDR signaling levels in PBMCs, hindering precise treatment effect quantification. To
address this, we've formed a collaboration with Rules Based Medicine (RBM) to develop a prototype "DDR boost
tube," an extension of RBM's TruCulture® immune activation blood tubes. DDR Boost tubes are blood culture
tubes containing a DNA damaging agent. Our preliminary data demonstrate that incubating blood ex vivo in the
DDR Boost tubes activates DDR signaling in PBMCs, boosting basal signaling levels, & improving pharmacody-
namic measurements. In cycle 2 of funding, we will translate the integrated technologies (DDR Boost tubes +
streamlined MRM assay) into clinical trials via the following Specific Aims: Aim 1: Optimize the design of DDR
Boost tubes to maximize MRM signal-to-noise ratios & develop a streamlined DDR MRM assay panel that seam-
lessly integrates with the tubes. Aim 2: Investigate biospecimen preanalytical variables affecting DDR measure-
ments using the optimized DDR Boost tubes & develop an evidence-based Standard Operating Procedure for
clinical trial laboratory manuals. Aim 3. Validate the DDR Boost tubes in a prospective clinical trial. Successful
completion of this project will deliver a clinically validated, next-generation solution for pharmacodynamic, proof
of mechanism, and correlative study measurements in the context of DDR-targeting therapies- and offer a blue-
print for applying a comparable approach to additional cell signaling networks with therapeutic potential.

Public health relevance
PROJECT NARRATIVE Measuring proteins in blood samples or tissue biopsies collected from patients participating in cancer clinical trials is essential to understand the effect of promising new treatments on the patient’s body and tumor. These measurements are critical for helping us to determine the best dose and treatment schedule for new cancer drugs, which are important for maximizing treatment success and minimizing side effects or toxicity. Unfortunately, current technological limitations hamper our ability to measure many proteins important to cancer treatment, and our team is working to solve this problem by translating novel technologies to overcome these limitations and thereby facilitate more efficient development of new therapies and improved abilities to select patients for personalized oncology approaches.